Biochemistry Core

1. Core utilization and accomplishments
- A total of 54 people from 23 laboratories have used for the facility services and instruments.
- Support investigators by implementing or developing methods for 1) mass measurement of intact proteins and organic compounds (a total of 3,158 samples from 23 laboratories), and 2) separation and quantification of proteins or metabolites by HPLC (a total of 1,861 samples from 8 laboratories).
- Applying a new method for the quantification of small organic compounds by HPLC or LC-MS and developing of a new sample preparation method to speed up data collection.

2. Core publications
-West, E., et al., CD4 T cell-intrinsic arginase 1 controls the kinetics of Th1 induction and contraction. Immunity (2023) accepted
-Narun, D., et al., Structural and Immunological Differences in Plasmodium falciparum stage transmission-blocking vaccines comprised of Pfs25-EPA nanoparticles. npj Vaccines (2023)
-Chea, C., et al., Macrodomain Mac1 of SARS-CoV-2 Nonstructural Protein 3 Hydrolyzes Diverse ADP-ribosylated Substrates. bioRxiv (2023)
-Ishiwata-E. H., et al., ARH Family of ADP-Ribose-Acceptor Hydrolase. Cells 11, 3853 (2022)
-Chen, J., et al., Glutamylation is a negative regulator of microtubule growth. Mol Biol Cell (2023) PMID: 37074962
-Nyenhuis, D., et al., HECT domain interaction with ubiquitin binding sites on Tsg101-UEV controls HIV-1 egress, maturation, and infectivity. J.Biol.Chem. 299, 10291 (2023)
-Watson, M., and Lee, J.C., Genetically Encoded Aryl Alkyne for Raman Spectral Imaging of Intracellular a-Synuclein Fibrils. J. Mol. Biol. 435, 167716 (2023)
-Szczesna, E., et al., Combinatorial and antagonistic effects of tubulin glutamylation and glycylation on katanin microtubule severing. Dev. Cell 57, 2497-2513 (2022)
-Lim, J., et al., Methionine sulfoxide reductases and cholesterol transporter STARD3 constitute an efficient system for detoxification of cholesterol hydroperoxides. J.Biol.Chem. (2023) in press
-Park, S., et al., Ndufaf2, a protein in mitochondrial complex I, interacts in vivo with methionine sulfoxide reductases. Redox Rep. 28, issue 1(2023)

3. New instrumentation and new services
-New TOF-LC/MS and UHPLC system for QTOF
-Glucosylceramide and glucosylsphingosine (Dr. Jennifer Lee lab)
-Separation and detection of Lactoylphenylalanine and its product (Dr. Alan Remaley lab)
-Sucralose and betaine in sputum and saliva (Dr. Ad Bax lab in NIDDK)
-Eicosanoids, including arachidonic acid (Dr. Nico Tjandra and Dr. Michael Sack labs)
-HILIC column separation with FLD for the separation of N6-etheno ADP ribose (ADPR, Dr. Joel Moss lab)
-Quercetin/Isoquercetin level in plasma (Dr. Arun Shet lab)
-Enzyme assay for desArgination of recombinant protein (Dr. Claudia Kemper lab)
-vitamin E in mice liver (Dr. Caroline Philipott in NIDDK)
-Native Protein mass spectrometry using TOF-LC/MS

4. FY23 budget
The budget spent 95% as of August 8, 2023.
- Maintenance contract for LC/MS---- 50%
- Repair part for the LC/MS -------- 10%
- Solvents and chemicals------------ 35%
- General consumables---------------- 5%